Defining the impact of host-directed drugs on Coxiella burnetii growth in macrophages

Coxiella burnetii is an intracellular bacterial pathogen that causes human Q fever. Q fever presents
most often as an acute flu-like illness but can present as fatal chronic endocarditis. Unfortunately,
treatment options for Q fever endocarditis are highly ineffective and require many months of antibiotic
administration. We recently discovered numerous host-directed drugs that suppress C. burnetii
replication within the pathogen’s target cell, the human macrophage. These drugs, which are typically
used to treat psychosis- or mood-related disorders by inhibiting neurotransmitter (NTM) system
signaling, potentially represent novel anti-Q fever therapies. The current proposal will define the
impact of NTM-acting drugs on the ability of C. burnetii to replicate within alveolar macrophages
and regulate the macrophage innate immune response to infection. Aim 1 will define the specific
NTM machinery involved in C. burnetii replication in macrophages. Aim 2 will define the impact of
host-directed drugs on the pathogen’s ability to dampen the cytokine response and shift alveolar
macrophages to a pro-replication, anti-inflammatory phenotype. Throughout the proposal, we will use
primary human alveolar macrophages and human precision-cut lung slices to provide disease
relevance. Collectively, the current proposal will lay the groundwork to characterize novel anti-C.
burnetii treatments.

Public health relevance
Coxiella burnetii causes the debilitating disease Q fever, a flu-like respiratory disease that can progress to chronic endocarditis. Although endocarditis is the most severe form of this disease, we currently have no effective therapeutics to combat this potentially fatal disease. The overall goal of this proposal is to characterize the impact of new host-directed drugs on C. burnetii parasitism of primary human alveolar macrophages, which will suggest potential as novel anti-Q fever therapies.